PepSAVI-MS for discovery of novel botanical antimicrobial peptides

ABSTRACT The continued evolution of antimicrobial resistance emphasizes the dire need for discovery of antibiotic therapeutics with novel mechanisms of action. Technological advances in genome sequencing, drug library creation, and structural informatics have not advanced infectious disease treatments sufficiently. While natural products have long served as inspiration for novel therapeutic scaffolds, we posit peptide-derived entities offer great potential to address current needs due to their unique mechanisms of action, penetration and selectively. Herein, we describe our PepSAVI-MS pipeline to discover and characterize peptides with antimicrobial activity through implementation of a hybrid bioassay-guided/peptidomics platform. We directly identify botanical peptides contributing to bioactivity profiles using robust microbial bioassays optimized for peptide screening and using a mass spectrometry-based peptidomics approach coupled to statistical modeling and informatics to identify and further characterize these peptides at the molecular level. These potential lead compounds are then tested against an extensive panel of clinical ESKAPE pathogens, as well as for favorable drug characteristics and determination of mechanism-of- action. Our platform enables robust mining of plants and other natural sources for peptidyl species with unique or broad-spectrum anti-infective properties and has the potential to lead to the discovery of novel chemistries at the forefront of modern drug discovery.

Public health relevance
RESEARCH STRATEGY Advancements in modern mass spectrometry have largely facilitated recent efforts in antimicrobial peptide (AMP) characterization strategies. Both de novo sequencing and proteomics database searching algorithms benefit from high resolution MS data, and both approaches are being heavily used in our efforts to identify novel antimicrobials – the main purpose of this R01 funding. In total, this project has resulted in nine original research publications, one review paper, and three additional papers submitted thus far (1-10). AMP mining via PepSAVI-MS requires screening a large quantity of samples from a fractionated library. The increasing age and limited sensitivity of our Sciex 5600 TTOF (purchased in 2011) have hampered our ability to acquire data on these sample sets. Due to the significant time requirement for screening of peptide libraries (~ 40 h/plant species), it is not feasible to utilize the core facility due to limited instrumentation access. In addition to screening, we have been leveraging high resolving power MS in innovative ways to accelerate AMP discovery / characterization. With increasingly available genomic and transcriptomic data from plants, we have coupled in silico AMP prediction with mass spectrometry-based proteomics/peptidomics for high- throughput bioactive peptide discovery. Bottom-up approaches were utilized to identify seven novel AMPs within Amaranthus tricolor, while top-down approaches were applied to three of these peptides in the enumeration of disulfide bonds, as well as in revealing proteolytic processing (10). These workflows have also resulted in the discovery of two novel AMPs (CC-AMP1 and CC-AMP2) from ghost pepper (Capsicum chinense x frutescens) with antimicrobial activity against E. coli and K. pneumoniae (manuscript submitted). High resolving power mass spectrometric approaches enabled determination of the full sequences, including post-translational modifications and specific connectivity of disulfide bonds. The rising threat of antimicrobial resistance calls for complementary methods to characterize mechanisms of action and define bacterial protein networks that confer resistance against a given antibiotic. To this end, we are leveraging quantitative bottom-up proteomics to examine the propensity for resistance to develop in bacteria. We began by evaluating resistance mechanisms employed by E. coli when treated with a common antibiotic peptide, polymyxin B. We were able to capture proteomic changes in known resistance mechanisms (Lipid A modifications, membrane porins, two-component systems, etc.). Intriguingly, we also detected an increased abundance of colibactin-producing enzymes, a small molecule genotoxin known to cause colorectal cancer (manuscript submitted). A similar approach was used to characterize the response of E. coli to a synthetic analog of an Amaranthus tricolor defensin (Atr-DEF2(G37-C54)) revealing the importance of outer membrane lytic and iron chelating activities when treated with the novel defensin (BMC Microbiology, accepted). These methods are being extended to characterize potential novel families of peptides (e.g. bacterial response to CC-AMP1 which has little homology with known AMPs). Mass spectrometry-based proteomics remains a powerful method for understanding the biomolecular mechanisms of antibiotic resistance by comparing bacterial protein abundances in different biological states. Our strategy to probe the differential proteomic landscape in response to acquiring AMP resistance will provide insight into developing novel antibiotics. Justification: Our laboratory's annual instrument needs are ~4,000 hours, mostly in 24/7 operation. With expected downtime due to cleaning, preventative maintenance, trouble shooting and repairs, this is close to 80% capacity on a given instrument. The performance of our Sciex TripleToF has been decreasing due to aging and relative to hardware innovations in the last decade. Thus, for the past 16 months our laboratory has been coordinating with the UNC-Chapel Hill Chemistry MS Core to operate their Q-Exactive HF-X instrument on a biweekly schedule to balance the needs of our lab as well as the rest of the department. This involves switching the instrument source from the HESI-II probe to the Nanospray Flex Ion source, establishing a stable spray, equilibrating the nanoLC, and running QC samples before any experimental samples are injected. This process typically takes ~12 h, which results in lost sample running time and week-to-week loss of reproducibility. While extremely useful, access to the department's instrument is not guaranteed or sustainable, and the deteriorating 5600s in our lab limit our long-term instrumentation options. Thus, this request to support the purchase of an Exploris 240 would not only provide sufficient accessibility, but would provide markable upgrades to our current system. The Exploris 240 uses an Orbitrap mass analyzer to achieve over 5x the maximum resolving power of the Sciex TripleTOF 5600, with a maximum of 240,000 at an m/z of 200. This expanded resolution, paired with a mass range of 40 – 6,000 m/z, enables enhanced analysis of both digested and intact peptides to facilitate de novo sequencing of antimicrobial peptides and their accompanying modifications. This is further enhanced through access to higher energy collisional dissociation for more efficient fragmentation. Whereas the 5600 is prone to mass drift and requires calibration every 4 – 6 h, the Exploris achieves < 3 ppm mass drift over 24 h, decreasing calibration frequency from approximately 28x per week to only once, thus enabling an extra 1,456 sample runs per year. Additionally, by using the AcquireX Data Acquisition Workflow, the MS will generate automatic exclusion lists to increase the depth of coverage of analysis. This will be exploited by modifying our current first 20 selection to the top 100 enabled by the Exploris. Recent comparison of E. coli proteome samples show we are able to attain a >100% increase in peptide spectral matches (PSMs) when acquired on the MS-core's Q-Exactive HF-X compared to our TripleToF 5600 (44,122 and 21,608 PSMs, respectively). This quantitatively highlights the increased depth of coverage that recent Orbitrap instruments are capable of, and the depth of coverage we expect in the requested Exploris 240. MAINTENANCE AND TRAINING We will continue to procure an instrument maintenance contract from the manufacturer or equivalent to ensure long-term viability / functionality of the requested Exploris 240. Two graduate students are assigned as leads for routine maintenance procedures. A senior experienced graduate student will serve as the primary contact for instrumentation issues and preventative maintenance, and a junior graduate student will serve as the secondary contact. This will ensure smooth maintenance transition periods as senior graduate students complete their studies. Furthermore, this gives the opportunity for graduate students particularly interested in instrumentation to establish skills early on in their graduate careers that are highly applicable to positions in both academia and industry. As a seasoned MS laboratory, we have robust and quantitative quality controls to ensure consistent instrument performance. On current instruments, we routinely inject both whole cell lysate and bovine serum albumin (BSA) digested samples to monitor chromatography, peptide identification, and peptide quantitation. Upon acquisition, runs are processed for quantitative accuracy and compiled in a report accessible to the rest of the lab members. To ensure proper instrument usage, all new lab members are trained in our standard operating procedures. This includes protein/peptide extraction from a biological source, sample preparation, instrument acquisition, and data processing. TIMELINE Upon approval, the order for an Exploris 240 will be placed immediately (by 07/01/2021), and delivery/installation by 09/01/2021. We will create/optimize methods, and compare and analyze QC samples that have run on our other platforms to get a baseline of the new system. By the end of September 2021, we expect to have all graduate students fully trained and running full time on the instrument. With a full-time functioning instrument in our lab, we anticipate significantly fewer delays and increased productivity with the Exploris 240.